Research Training for Anesthetists

ABSTRACT
We seek to continue a postdoctoral research training program for anesthesiologists, now in its 45th
year, in order to develop skilled physician-scientists who will expand knowledge and ultimately improve
clinical delivery of patient care in core practice areas of anesthesiology: perioperative medicine, critical
care, perinatal care, and pain management. We propose to offer ten carefully selected
anesthesiologists the opportunity to train with an outstanding investigator-mentor in one of the research
programs at the Harvard Medical School or its affiliated institutes and hospitals, for a period of 2 or 3
years. A national pool of candidates is recruited, with Harvard-affiliated academic anesthesiology
programs providing an enriched source of highly capable and motivated residents and fellows. Special
efforts are made to establish and maintain diversity through recruitment and retention of individuals
from underrepresented racial and ethnic groups, disabled individuals, and those from disadvantaged
backgrounds. The training program is structured as a tutorial, individualized to meet the specific needs
and research interests of each trainee. Research areas include, but are not limited to: biochemistry,
bioengineering, biophysics, clinical outcomes, endocrinology, epidemiology, genetics, immunology,
metabolism, molecular biology, neurobiology, nutrition, pharmacology, physiology, and toxicology. To
best match the needs of trainees, faculty mentors are selected or recruited, based on their expertise
and experience, funding record, and demonstrated ability to help mentees succeed in achieving
research independence, including independent extramural support. Trainees will also undertake
course-work tailored to their individual experience, needs, and goals, which may include the completion
of graduate certificates or degrees. Training in responsible conduct of research and research rigor will
be required. The program’s long-term goal is to increase the number of anesthesiologists with the
knowledge, skills, and determination to become independent researchers focused on questions of
importance to anesthesiology and the basic sciences upon which it rests. The participating Harvard-
affiliated academic anesthesiology departments, in which trainees will hold clinical appointments, are
committed to their long-term career development beyond completion of this program. These trainees
are expected to enrich the next generation of research leaders and mentors, as the needs of patients
evolve and the medical discipline of anesthesiology optimally responds.

Public health relevance
PROJECT NARRATIVE Anesthesiologists are medical specialists that lead care teams managing a wide range of patients undergoing procedures, in critical care units, and suffering from pain. This project will train selected anesthesiologists to perform scientific research, so that they may become future leaders whose research efforts will improve the practice of anesthesiology, resulting in better patient care.